Metalloregulation by MerR and Fur Protein Families

PROJECT SUMMARY
There is a growing need in the biomedical research community to understand the fundamental roles and
mechanisms that regulate inorganic chemistry involved in cellular physiology. While many of these metals have
been labeled as ‘trace elements,’ from a cellular point of view this is a misnomer: the intracellular concentrations
of zinc and iron are routinely maintained at much higher levels (i.e., 0.6 mM). These insights, as well as the
emerging literature linking metal physiology to many human disease states, underscore the importance of
establishing the fundamental principles, general pathways, and macromolecular mechanisms employed to
manage the large numbers of metal ions required for optimal health of a cell.
Our approach to the discovery of these novel pathways and principles involves mechanistic and structural
characterization of metal receptors that switch on and off genes in a metal dependent manner and that
subsequently control the activity of cellular machinery that maintains metal concentrations within narrow ranges.
There are three principle thrusts in this proposal: a) determining how zinc regulons are controlled by
metalloregulatory switching events through newly discovered protein-RNA interactions; b) establishing
mechanisms for how copper, zinc, and mercury sensing metalloregulatory switches control the topology of DNA
within an RNA polymerase promoter complex, and then applying these insights to the development of new types
of metal ion sensors, and c) developing quantitative metallomic methods that enable researchers across the
biomedical research continuum to address the question of how quantitative inorganic phenotypes vary across
cells involved in commensal or pathophysiological interactions with the human host.
Overall, these aims focus on resolving fundamental questions about the structures, functions, and molecular
mechanisms of wide-spread families of metal-sensing metalloregulatory proteins. The proposed experimental
approach will employ x-ray crystallography, biophysical methods, single particle cryo-electron microscopy,
proteomic, bioanalytical, spectroscopic and bioinformatic methods to understand the pathways that
microorganisms use to respond to changing metal ion availability in the growth media, or in the mammalian host.
The effects of these biophysical switching mechanisms on intracellular metal physiology will then be examined
using novel single cell analytical and imaging methods coupled with traditional batch quantitative measurements
with the overarching goal of establishing general principles and mechanisms that control metal ion homeostasis
in normal and disease states.

Public health relevance
PROJECT NARRATIVE This proposal focuses on the structure and function of metal ion receptors that translate fluctuations in metal ion availability into changes in cellular physiology. These studies of metalloproteins will reveal fundamental mechanisms that cells use to control essential but potentially dangerous factors. Rigorous control of the biological activity of metals is important as cellular metal imbalances can lead to a variety of disease states.